Columbia University/Aga Khan University Global Network Research Unit

Project Summary
The Aga Khan University/Columbia University (AKU/CU) Global Network Research Unit is applying to continue
its membership in the Global Network for Women's and Children's Health Research (Global Network [GN]). At
CU, the project is located in the Department of OBGYN and at AKU within the Department of Community Health
Sciences (CHS). To date, our site has been among the most productive in the GN. We have fully participated in
all aspects of the GN from developing successful concepts for single site and common protocols to leadership
on GN committees. We have acquired non-GN funds both to support GN multisite projects and to strengthen the
Department of CHS at AKU. We have proven access to large urban and rural populations and have successfully
performed many hospital-based and community-based studies. We have contributed more clusters to the GN
Registry and cluster-randomized trials than any other site. Our follow-up rates and the quality of our data are
excellent. Over the 22 years in the GN, we have enrolled nearly 300,000 women and children into GN projects
and authored over 300 papers. In the next 7 years, we plan to continue or surpass this level of engagement as
detailed below. As part of the GN, we will conduct multi-center trials of interventions for pregnant women,
newborns and children to reduce their mortality and morbidity in Pakistan and other low-resource countries. We
understand that the specific projects will be chosen by a stand-alone committee and these could originate either
from a GN investigator or an investigator from outside the GN. We will continue to maintain a population-based
registry of pregnancies and their outcomes in Pakistan, to measure trends and factors associated with those
outcomes and to compare risk factors and outcomes to other GN sites. We will continue being a leader among
the GN sites in protocol development, subject recruitment, data quality and obtaining outside funding for GN
projects and continue to stimulate the development of Pakistani researchers and promote collaborations between
AKU researchers and those from CU and other US sites. We will continue to attract new Pakistani and US
investigators to global maternal and child health research by systematic mentoring of junior investigators and
recruiting senior scientists from related fields, and to continue enhancing the research environment at AKU by
providing high-quality administrative, financial, statistical and research support services within a scientifically
stimulating multidisciplinary setting. We also will continue to support government endeavors to strengthen the
health system in our research site by facilitating training on new cost-effective interventions suitable for countries
with limited resources. Because of the many strengths of our research team and its dedication to improving the
health of women and children in low-resource settings, as well as its long history of collaboration within the GN
and with many entities in Pakistan, we strongly believe that the goals described above will be achieved almost
immediately and continue indefinitely, and that the AKU/CU site will continue to be a leader in the GN.

Public health relevance
Project Narrative The Aga Khan University/Columbia University Global Network site has played an important role in each of the Global Network studies and is responsible for both the conceptualization and leadership of several important research projects. In recent years, the Global Network has evaluated the value of ultrasound examinations during prenatal care, aspirin use to reduce preterm birth, a multi-micronutrient supplement to reduce childhood stunting, antibiotics during labor to reduce perinatal infections and the impact of COVID – 19 infections on pregnancy outcomes, all in the low and middle-income countries. The goal of future studies will be to continue to provide insight into the causes of adverse outcomes for women and children in low and middle-income countries, to evaluate medical and public health interventions designed to improve those outcomes and make data available so that the medical and public health systems in low and low-middle income countries can utilize the best evidence based interventions to improve the health of women and children.